Training Grant in Clinical Pharmacology

ABSTRACT
This proposal is a request for continued funding of the NIH-sponsored Clinical Pharmacology T32
Fellowship Training Program at the Mayo Clinic. The foundation for this long-running program is strong
training in state-of-the-art biomedical research as applied to human-drug interactions, i.e., Clinical
Pharmacology. The Mayo Clinical Pharmacology training experience includes a curriculum that exposes
Trainees to the rapidly evolving science that underlies Clinical Pharmacology. However, beyond a strong
curriculum that includes pharmacokinetics, drug metabolism and pharmacogenomics, at the heart of
the Program are outstanding individual research experiences within a supportive mentoring
environment. Clinical Pharmacology lies at the confluence of molecular pharmacology, multiple
“omics” and, increasingly, exciting analytical techniques such as Artificial Intelligence and Machine
Learning—techniques that this center has embraced and applied to studies of drug mechanisms and
drug response. The union of these analytical techniques with the leadership that the Mayo Clinic Program has
demonstrated over the years in the application of “multiple omics” to Clinical Pharmacology will help move us
closer to the twin goals of truly “individualized” and “rational” drug therapy. We propose to take advantage of
the opportunity represented by the dramatic advances occurring in biomedical and computational
science to train the next generation of Clinical Pharmacologists by joining the latest laboratory-based
pharmacologic science with modern computational techniques to enhance mechanistic understanding
and the predictability of drug response. Comprehensive, highly integrated academic medical centers like
the Mayo Clinic are ideally positioned to address this challenge. The Mayo Clinic has a history of performing
and integrating outstanding basic and clinical medical research as well as a tradition of continuing contributions
to the discipline of Clinical Pharmacology and decades of experience in recruiting and training both physician
scientists and laboratory-based translational scientists in Clinical Pharmacology. During the next funding cycle,
the Mayo Clinical Pharmacology Fellowship Training Program will continue to emphasize strong laboratory-
based research training in a supportive mentored environment joined with a continually evolving curriculum
and systematic exposure to advances in biomedical and computational science—all directed toward the goal
of preparing each Fellow enrolled in the Program to become a future leader in Clinical Pharmacology in
academia, in industry and in regulatory agencies.

Public health relevance
NARRATIVE Clinical Pharmacology is the scientific discipline that addresses all aspects of human-drug interactions, including mechanisms of drug action and the mechanistic basis for individual variation in drug response. Clinical Pharmacology is undergoing rapid change with the integration of “multiple omics” science and modern computational techniques such as artificial intelligence and machine learning. The long-standing Mayo Clinic Clinical Pharmacology Training Program has embraced these advances and incorporated them into a Training Program designed to prepare healthcare professionals to contribute to our understanding of human drug interactions by the application of all of the tools of modern biomedical and computational science.